Administrative Core

The specific aims of the Administrative Core (A) are to provide centralized scientific and administrative management, financial control services, and clerical and materials management support to all projects and cores. The Administrative Core will provide necessary support for the organization and conduct of the Steering Committee /Internal Advisory Board meetings, the annual Investigator Meeting and Retreat with the External Advisory Board, and monthly or as-needed telephone, video, and web conferences. This core supports the mission of the NCI to improve the treatment and continuing care of cancer patients.

Public health relevance
RELEVANCE (See instructions): This research aims to improve radiation treatment for cancer patients by improving our ability to direct the radiation at the tumor to spare adjacent normal tissue by using protons (charged particles) with intensity- modulated proton therapy. This can potentially improve cancer cure rates, reduce side effects, or both, depending on the clinical scenario. With an increasing number of proton centers in the United States and abroad, the research in this program project is increasingly important for public health.